PROTROPIN PHASE IV MULTI-CLINIC STUDY OF THE SAFETY AND EFFICACY OF PROTROPIN

Previously treated growth hormone deficient children are being treated with Protropin growth hormone to compare growth response to daily or three times a week dosage schedule. Genentech is sponsoring this study until final adult height is reached.